INFRASTRUCTURE FOR REMOTE COLLABORATION & COMMUNICATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Our expansion of the collaborative and service research requires an efficient and cost effective means of communication with the remote collaborators. We are implementing different capabilities and options with improving successes.